Leadership, Planning and Evaluation

Project Summary/Abstract
LEADERSHIP, PLANNING AND EVALUATION
Strategic planning and evaluation at Perlmutter Cancer Center (PCC) occur in a regular and systematic manner
across all mission areas to ensure a consistent and uniform framework for the future, and are grounded in the
Center’s mission of “bringing visionary thinking and compassionate care to the science of treating cancer.” The
guiding principle at the heart of PCC has been to attract and retain the best and brightest scientists, clinicians
and staff members, who share a common goal of advancing the field of cancer research, education and patient
care beyond what may have been possible in NYU Langone Health’s past. This goal is admittedly lofty, but one
that the Senior Leadership of the Cancer Center are committed to accomplishing. To this end, PCC senior
leadership has been overhauled almost completely, with a new deputy director, five new associate directors, and
eight new program leaders to provide the experience, direction and diversity necessary to implement our new
Strategic Plan. In line with our altered strategic focus, we have also reshaped our External Advisory Board, while
engaging in continuous leadership and planning evaluation.
!